Proteomics Core

ABSTRACT, Proteomics Core (PC)
The Indiana University Simon Comprehensive Cancer Center (IUSCCC) Proteomics Core (PC) provides state-
of-the-art mass spectrometry-based quantitative and qualitative proteomics analyses. We have established
standardized methods for sample preparation and mass spectrometry analysis for global untargeted proteomics,
phosphoproteomics, thermal proteome profiling, and targeted mass spectrometry analysis of specific targets of
interest. In the current grant period, we have established the infrastructure and technical expertise to perform
analyses of >100 samples for a single project by discovery proteomics. This work will be extended to targeted
proteomics studies in the next funding period. With IUSCCC support, we are also implementing the Olink Explore
technology as a joint service between the PC and the Genomics Core. Olink has focused its targeted proteomics
target selection for its Explore platform to proteins that are present in human biofluids such as whole blood in a
wide dynamic range. Olink Explore has become a highly complementary approach to mass-spectrometry-based
discovery proteomics; by offering both types of proteomics services, we will be able to meet the needs of all
IUSCCC members over the next grant period. Additional efforts include ongoing and new development of
targeted proteomics assays for proteins of interest for IUSCCC users. We will also continue our efforts to provide
education and training for IUSCCC users and members of their laboratories on all established and emerging
technologies provided by our Shared Resource.